Training in Pediatric Infectious Diseases

PROJECT SUMMARY/ ABSTRACT
This is a renewal application from Columbia University Irving Medical Center to obtain continued
support for our post-doctoral training program Training in Pediatric Infectious Diseases. Dr. Lisa
Saiman and Dr. Alice Prince will be the PDs/PIs under the multi-PI model. Both are established
investigators with complementary research interests. Both have long-standing commitments and
experience training young physician scientists from many disciplines and a long track record of
success. The goal of this training grant is to train post-doctoral fellows (MDs or MD PhDs) in
state-of-the-art multidisciplinary research training in Pediatric Infectious Diseases in order to
develop research careers in basic, translational, clinical, and/or epidemiologic investigation in
academic settings and/or in the public health sector. The research focus of the training program
reflect three complementary, overlapping areas of research involving Host-Pathogen
Interactions: microbial pathogenesis, immune responses to microbial pathogens, and public
health/ healthcare delivery to address microbial pathogens. We are requesting 5 more years of
funding for 3 post-doctoral fellow trainees per year. We have chosen highly collaborative,
multdisciplinary faculty with expertise in Host-Pathogen Interactions to serve as training
preceptors. We are expanding our applicant pool to include trainees from other pediatric
disciplines who choose to pursue infectious diseases research relevant to their subspecialty
area. The training grant will support the trainees during their 2nd and 3rd year of subspecialty
training during time which they will be engaged in scholarly research guided by an experienced
mentor. Drs. Saiman and Prince will be supported by feedback from the Internal and External
Advisory Committees, and committees focused on Trainee Recruitment/Selection,
Research/Mentorship and Career Development. This training program is unique at our institution
and will allow us to train future academic leaders.

Public health relevance
Project Narrative This is a renewal application from Columbia University Irving Medical Center to obtain continued support for our post-doctoral training program Training in Pediatric Infectious Diseases. The goal of this proposal is to train post-doctoral fellows (MDs or MD PhDs) to develop research careers in Pediatric Infectious Diseases. This training program will allow us to provide trainees with the skills they need to become future academic leaders and the tools they need to meet future infectious disease threats.